A Molecular Approach to Dissecting MEK-Mediated Phosphorylation in Pediatric Leukemia

SUMMARY
Acute lymphoblastic leukemia (ALL) is the most common hematological malignancy and the leading cause of
cancer-related death in children in the United States. Multi-drug chemotherapy has vastly improved 5-year event-
free survival by over 80%; however, the prognosis for children with refractory or relapsed disease is less positive,
with complete remission rates dropping to 30%.
Mitogen-activated protein kinase (MAPK) signaling pathways are conserved across eukaryotes from
yeast to humans. These enzymes play a central role in regulating cellular activities from survival and proliferation
to stress response, differentiation, motility, and angiogenesis. MAPK pathways couple diverse extracellular
signals (growth factors, hormones, cytokines, and environmental stresses) to distinct intracellular gene programs
via a series of activating phosphorylation events. Providing direct input to these kinases are the MAPK/ERK
kinase (MEK) family enzymes, also called mitogen-activated protein kinase kinases (MAP2K or MKKs).
Currently, there are four FDA-approved MEK inhibitors which block inputs to the ERK1/2 arm of the pathway, all
of which inhibit MEK1/2. Loss of MAP2K7 (a.k.a. MEK7) repression and consequent amplification of downstream
mitogen-activated protein kinase (MAPK) signaling is thought to contribute to T-cell acute lymphoblastic leukemia
(T-ALL) pathology. Currently, the only known function of MEK7 is the phosphorylation of JNK, its downstream
signaling partner in the MAP kinase signaling cascade. However, its structurally and functionally homologous
isoform MEK4 also functions to phosphorylate this downstream kinase. The relative inputs of MEK4 and MEK7
seem to be variable and context dependent. This gap in the knowledge is currently a major impediment to fully
understanding MEK signaling pathways in the context of cancer. Although both MEK4 and MEK7 activate JNK,
only MEK7 appears to mediate JNK-dependent inflammatory responses in immune cells. Likewise, it is possible
that inhibition of MEK7 in the context of T-ALL may lead to compensatory upregulation of MEK4-promoted JNK
phosphorylation. Equipped with highly selective MEK7 inhibitors, we are uniquely enabled to dissect this critical
kinase cascade for the first time. Herein, we propose the further development of new molecular tools to attenuate
MEK7-mediated JNK phosphorylation. These new probe compounds will then be applied to the cellular
dissection of the JNK arm of the MAP kinase signaling cascade in the context of T-ALL. Clinically relevant mouse
models will then be employed to identify the optimal drug target(s) in T-ALL.

Public health relevance
NARRATIVE Acute lymphoblastic leukemia (ALL) is the most common hematological malignancy and the leading cause of cancer-related death in children in the United States. The MEK signaling pathway plays a key role in the progression of T-cell ALL (T-ALL). We have demonstrated that MEK7 is upregulated in this disease, and it causes disease progression by upregulating another kinase, JNK. We plan to develop selective inhibitors for MEK7 to study the activity of these kinases in T-ALL in vivo. This advance will allow for unique insights delineating the role of MEK7 in T-ALL and validating these kinases as potential new drug targets.